Research Training in Rheumatology at Massachusetts General Hospital

This is the 40th year of this highly successful research Training Program in Rheumatology at Massachusetts
General Hospital (MGH) and Harvard Medical School (HMS), supported by training grant T32 AR07258. The
goal of this program is to train MD, MD/PhD and PhD post-doctoral fellows for independent investigative
careers in rheumatology research. Of the 58 graduates of the program that were directly supported by this
training grant, many now have faculty appointments in academic medical centers, including holding leadership
positions at major institutions as Deans, Scientific Directors, and Division Chiefs. Our program centers on our
outstanding clinical Rheumatology fellowship and our strong basic, translational, clinical science and clinical
epidemiology research programs. The MGH Rheumatology T32 Training Program is situated within a vibrant,
technologically-innovative research environment. Our program provides supervised laboratory, clinical and
health outcomes research under the guidance of accomplished faculty members, as well as structured training
in rheumatology, immunology, clinical trials, epidemiology, biostatistics and ethical issues through courses or
conferences. The basic science research focus of the program is the study of the immunopathogenesis of
rheumatic disease. Areas of particular interest include autoimmunity, innate immunity, leukocyte trafficking,
inflammation, infectious causes of rheumatic diseases and the microbiome, systems immunology, fibrosis, and
stem cell biology. Disease areas of particular interest include rheumatoid arthritis, lupus, scleroderma, Lyme,
gout, systemic vasculitis and IgG4-related disease. The clinical science research program focuses on
population and health care sciences in rheumatic diseases. This application requests 4 training positions that
will be allocated to trainees who are committed to at least 2 to 3 years of research training. The candidates will
be recruited from the MGH Rheumatology fellowship and from post-doctoral trainees already working in the
laboratories of faculty mentors. Seventeen faculty members primarily from the MGH Rheumatology Unit and
its affiliated Center for Immunology & Inflammatory Diseases (CIID) participate in this T32 Training Program.
Faculty mentors were carefully chosen based on their track record of publications, grants, collaboration,
mentoring, and mutual interest in rheumatology, immunology and health care sciences. The Training Program
leverages many of the research centers at MGH, including the Ragon Institute, Cancer Center, Center for
Regenerative Medicine, and Mongan Institute. The MGH provides an outstanding training environment and is
home to the largest hospital-based research enterprise in the U.S., with an annual budget of $912 million in
2017 comprising more than 8,500 researchers. Opportunities at Harvard, including course work and the NIH-
funded Harvard Clinical and Translational Science Center, as well as the Broad Institute provide additional
resources for trainees. In sum, in this renewal application represents a cohesive, integrated, high-quality
Training Program in basic, translational, clinical and health outcomes research in the rheumatic diseases.

Public health relevance
Project Narrative Research Training in Rheumatology at the Massachusetts General Hospital is designed to prepare the next generations of research scientists who, through mentored research and rigorous training in new technologies, are prepared to be leaders in rheumatology related biomedical research. The overall goal of this Training Program is to educate trainees so that they can contribute to our understanding of the pathogenesis of rheumatic diseases, and translate these findings to better clinical care for patients with these important diseases.